Developmental Funds

DEVELOPMENTAL FUNDS: PROJECT SUMMARY
Developmental Funds are critical to promote synergistic, collaborative research that is aligned with the Herbert
Irving Comprehensive Cancer Center (HICCC) strategic plan and fueled by our Catchment Area. The HICCC
continues to utilize Developmental Funds in a strategic manner, facilitating high-priority research with high
probability of external grant funding, fostering the research careers of junior investigators, facilitating team
science, increasing translational and clinical research, and promoting new research areas relevant to the
Catchment Area. During the project period, HICCC invested a total of $4.4M in 39 pilot projects. Of this total,
$856,000 in Cancer Center Support Grant (CCSG) Developmental Funds funded 14 pilot projects. These
projects have led to $15.3M in external grant funding, a nearly 18-fold return on investment. From 2017 to 2019,
HICCC also funded 15 pilots using $2.1M non-CCSG funds made possible through philanthropy and industry
funding. A new funding partnership in 2019, with the Emerson Collective Cancer Research Fund, provided an
additional $1.44M which funded nine high-risk, high-reward projects in its first year. Lastly, $17M in non-CCSG
Developmental Funds, derived from a combination of institutional, philanthropic, and industry funds, were used
for Shared Resources.
In this application, the HICCC requests $300,000 per year in Developmental Funds, an increase of $123,000
per year and 7% of the total CCSG budget request (direct costs). These funds will be utilized to meet the following
interrelated Specific Aims: (1) Award pilot projects to HICCC investigators to promote team science, high
risk/high reward ideas, junior investigators, and pre-clinical and clinical concepts; (2) Invest in Shared Resources
in order to support leading-edge research and priorities set forth in the 2019-2025 strategic plan; and (3) Support
the planning of multi-investigator grants (e.g. P01, U01/U54, SPOREs) that aim to foster transdisciplinary
collaboration.